Elucidating the Interplay Between DDX41 and CUX1 Mutations in Hematopoiesis in Danio Rerio and iPSCs

PROJECT SUMMARY
Myelodysplastic syndromes (MDS) are a family of bone marrow failure disorders involving defective
hematopoietic stem and progenitor cells (HSPCs). In MDS, there is clonal expansion of defective HSPCs over
healthy cells, ineffective maturation and uni- or multilineage cytopenias of myeloid lineage cells, and increased
risk of transformation to acute myeloid leukemia (AML). Although the field recognizes the effects of MDS, the
origins and evolution of its pathogenesis are incompletely understood.
Somatic and germline mutations contribute to MDS/AML formation by altering HSPC proliferation, differentiation,
and survival. Heterozygous germline mutations of DEAD-box helicase 41 (DDX41) predispose individuals to
hematologic malignancies, especially MDS/AML. Despite carrying the mutation throughout life, patients typically
do not develop MDS until later in adulthood, which suggests secondary factors play key roles in driving disease.
Researchers identified a strong enrichment for co-occurrence mutations in DDX41 and CUT-like homeobox 1
(CUX1), which encodes for a nonclustered homeodomain transcription factor and tumor suppressor gene and
may act as a secondary somatic driver mutation in DDX41 patients. My project aims to delineate how co-
occurring ddx41 and cux1 mutations cooperate to drive hematopoietic dysfunction using zebrafish and human
induced pluripotent stem cells (iPSCs). In vivo, in zebrafish, I will characterize the blood system during
embryogenesis by assessing changes in HSPCs, and differentiated progeny, including erythroid cells. In adult
zebrafish, I will evaluate if mutations in cux1 paralogs accelerate or exacerbate hematopoietic decline and
assess changes in age-associated clonal HSPC expansion, using Zebrabow, a novel method that utilizes a Cre-
lox system to induce a heritable color barcoding unique to each HSPC and its progeny. To determine if our
findings are conserved in humans, I will also assess HSPC levels and hematopoietic differentiation into
erythrocytes in human iPSCs with a common germline DDX41 mutation in combination with CUX1 mutagenesis.
These experiments will provide mechanistic insight into how these common co-occurring mutations might drive
hematopoietic dysfunction and ultimately contribute to the development of MDS/AML.

Public health relevance
PROJECT NARRATIVE Myelodysplastic syndrome (MDS) is amongst the most common hematological malignancies of the elderly, with limited treatment options and understanding of disease pathogenesis, and may often progress to acute myeloid leukemia (AML). While germline mutations in the DEAD-box Helicase 41 gene (DDX41) have been identified in patients with MDS, it is not yet understood what secondary factors or genetic aberrations drive DDX41 germline patients from quiet to smoldering disease; thus the goal of my proposal is to delineate how DDX41 and a highly common secondary mutation in CUT-like homeobox 1 (CUX1) cooperate to drive hematopoietic dysfunction. Understanding the mechanisms behind the disease pathogenesis of hematological malignancies is clinically important because it can provide novel diagnostic or therapeutic avenues for MDS patients.